Epigenetic Modifiers to treat Photoreceptor Degenerations

Abstract:
The overall goal of Skyran Biologics is to develop powerful topical therapeutics to combat retinal
degenerative diseases. In the course of our studies on epigenetic regulation of retinal development we have
defined ways in which histone modifications can lock genes encoding these mechanisms into inactive,
condensed chromatin. We found a number of drugs that partially reverse chromatin condensation without any
obvious loss of normal cell function. More importantly, these epigenetic modifiers prevent photoreceptor
degeneration in models of Retinitis Pigmentosa. In addition to histological and molecular preservation,
treatment also reduced loss of visual acuity and contrast sensitivity. Based on our published and preliminary
studies, we hypothesize that such drugs can be used to reverse chromatin condensation and allow
photoreceptors to respond to and survive disease stresses. This innovative approach to target retina
degeneration through changes in chromatin compaction has a strong translational implication as it is mutation
independent. From our studies, we selected a lead candidate and now propose two specific aims to address
important scientific questions about photoreceptor degeneration. The first is effective delivery of the drug.
Epigenetic modifier drugs often show systemic side effects. Topical targeted delivery to the eye will prevent
systemic concentrations from reaching a threshold for such effects. Second, although we have data
supporting our hypothesis that chromatin decondensation is the key effect of epigenetic modifier drugs, and so
should be effective for many photoreceptor degenerations, we have not tested efficacy using different models
of both Retinitis Pigmentosa and Age-Related Macular Degeneration (ARMD).
In our first Specific Aim we will use our most potent drug, GSK2879552, to test the most effective
dosage and frequency of topical treatment that blocks rod degeneration in C57Bl/6rd10 mutant mice.
In our Second Aim we will test efficacy of GSK2879552 on two additional models of photoreceptor
degeneration, namely the Rho-P23H transgenic mouse, an additional model of Retinitis Pigmentosa, and the
Abca4-/-Rdh8-/- double knockout mouse, a model of ARMD. Results of these aims will define the generality of
our hypothesis, important mechanisms and treatment of photoreceptor degeneration, as well as help delineate
the potential size of the market.
The milestones achieved by the successful completion of these aims will position us to propose a set of key
Phase II studies using GMP grade material, including systemic toxicity screening, dosing, formulation, and
biostability studies that will move us towards an IND filing and human trials.

Public health relevance
Narrative: Epigenetic modifications control the development and survival of cells in the retina. Skyran and its academic partner are developing a small molecule therapeutic to prevent cell loss in photoreceptor degenerations. This novel drug will significantly simplify the treatment of Retinitis Pigmentosa, and possibly Age-Related Macular Degeneration, through the use of an eye drop formulated therapeutic that has the potential to significantly reduce or halt photoreceptor degeneration in the retina, thereby reducing or eliminating loss of sight caused by these diseases.